Center for Somatic Cell Genome Editing in Nonhuman Primates

Overall
PROJECT SUMMARY / ABSTRACT
The Center for Somatic Cell Genome Editing in Nonhuman Primates will fully support studies that will
advance the somatic cell genome editing field, and significantly contribute to the future translation of new and
emerging technologies for the treatment of human diseases. The Nonhuman Primate Testing Center brings
together a robust team of multidisciplinary investigators with partnerships that capitalize on major strengths at
UC Davis including the California National Primate Research Center, Genome Center, and Clinical and
Translational Science Center. The program will provide unique state-of-the-art capabilities for investigators to
conduct high-quality research in nonhuman primates. The Nonhuman Primate Testing Center leverages a
supportive framework that has demonstrated a long-standing commitment to outreach and providing
collaborative opportunities to investigators nationwide to advance their translational preclinical research goals,
including progression to human clinical trials. Through this powerful and proven infrastructure, the Center for
Somatic Cell Genome Editing in Nonhuman Primates will address the following Specific Aims: (1) Provide an
administrative and organizational structure to advance somatic cell genome editing studies targeting a range of
human diseases in all age groups, (2) Partner with investigators to accelerate their translational research
objectives, and (3) Ensure synergism and sharing across the small and large animal testing centers and
transparent interactions with the research community and the NIH. Our robust multidisciplinary team is poised
to continue our national role and service to the research community by bringing the depth and breadth of
opportunities available to support investigators, and safely advance somatic cell genome editing technologies
to new treatments for human diseases.

Public health relevance
Overall PROJECT NARRATIVE The Center for Somatic Cell Genome Editing in Nonhuman Primates will serve the research community by supporting innovative studies in nonhuman primates to identify safe and efficient treatments for human diseases. The program will ensure essential resources, expertise, and research opportunities are available for investigators nationwide to advance new and emerging genome editing therapies for patients in need across all age groups, and in a collaborative multidisciplinary setting that promotes transparency and data sharing.